Production of antibody therapeutic fragments by reduced genome E. coli in continuous culture

Scarab Genomics’ C-Flow™ technology is a highly efficient continuous culture system that can produce
kilograms of protein in a few weeks at a mere 10-liter scale. This project will determine whether C-Flow can be
further developed as an efficient system for production of single-chain antibody therapeutics.
Antibody fragments, especially single-chain variants, are increasingly important for diagnostic and therapeutic
use such as toxin and virus neutralization, being relatively easy to manufacture in E. coli, albeit very inefficiently
in current techniques. They are of great potential significance as therapies for outbreaks and biothreats, with
notable success against Ebola in West Africa. Other antibodies are remarkably successful for e.g. treatment of
cancer and autoimmune diseases. These molecules have a variety of structures and indications but severe
problems in manufacturing. Lacking glycosylation, antibody fragments are short-lived in vivo, requiring multiple
high doses, leading to prohibitively expensive drugs. Therefore, a method of production that is fast, efficient, and
low in cost is critically needed. This project will optimize C-Flow production of three structurally distinct single
chain fragment antibodies, to evaluate the general applicability of the approach. The goal is high expression
levels and sustained production on an unprecedented scale with small-footprint equipment.
Correct folding of antibody fragments is critical for function. E. coli mechanisms for expression and delivery into
the periplasm, where protein folding occurs, include chaperones, signal sequences, and codon usage and
distribution. These mechanisms will be optimized for all three antibody fragments. Computer predictions have
the power to reveal folding defects that could be corrected by genetic engineering to replace residues or regions
that do not fold well. By testing an example immunotoxin that does not express strongly, the possibility of using
software predictions for rational antibody design for increased manufacturability will be explored. Engineered
changes suggested by computer predictions will be implemented and evaluated. Such an integrated system of
software and production technology could provide a rapid response to a bio-emergency, going from outbreak to
therapeutic ready for clinical testing in weeks. The Specific Aims are:
1. Optimize production of a structurally simple antibody fragment, scFv-SG1, at 1-liter then 10-liter C-Flow
scales, extending the latter to at least 30 days to evaluate continuous antibody production.
2. Optimize production of a more structurally complex antibody fragment, scFabYMF10 as per Aim 1, purify
the antibody and test its function by evaluating scFabYMF10 binding to its target antigen.
3. Enhance expression of the antibody-toxin conjugate B3Fv-PE40 (poorly expressed in E. coli) using
physiological and genetic engineering approaches. Determine whether up-front software-assisted design of
the protein can be used to predict improved manufacturability.

Public health relevance
Scarab Genomics seeks to radically improve cost-effective manufacturing of antibody fragments, which are the most important recent development in therapeutics. The ability to produce antibody therapies in large quantities impacts high-dose regimens where sustained production is critical, and the ability of the US to defend or treat its citizens in the event of an outbreak or biological threat. Highly economical production also has the potential to make personalized treatments possible.